Neuronal cannabinoids

DESCRIPTION (provided by applicant): CB1 cannabinoid receptors mediate the psychoactivity of cannabis, the most commonly abused illicit drug, and are also attractive therapeutic targets. Sustained CB1 receptor activation, as happens with heavy cannabis use, or if CB1 agonists are used therapeutically on a regular basis, leads to the development of behavioral tolerance - that is, more drug is required to produce the same effect. Earlier studies by us and others in simple preparations (e.g., cell culture models) indentified two serines in the C-terminus of the CB1 receptor whose phosphorylation desensitized CB1 signaling. To test the hypothesis that phosphorylation of these residues was necessary for the development of behavioral tolerance in an animal, we made a knockin mouse mutating these two residues to alanine (S426A/S430A). In preliminary experiments we have found that these mice, compared to wildtype mice are more sensitive to Δ9tetrahydrocannabinol (THC), develop tolerance to repeated administration of THC more slowly and also recover from tolerance more rapidly. In the proposed work we will use these mice as a novel model system to address significant questions relating to the development and expression of tolerance to CB1 receptor agonists by completing three specific aims: 1. What is the role of CB1 receptor serines 426 and 430 during the development of tolerance to cannabinoids? By using our S426A/S430A knockin mouse we will determine the role of phosphorylation of these two serines in the acute response to cannabinoids, in the development of cannabinoid tolerance and dependence, and in the severity of precipitated withdrawal. 2. How does preventing phosphorylation of serines 426 and 430 affect CB1 signaling during tolerance? In these experiments we will use biochemical and electrophysiological approaches (GTPγS autoradiography, MAP kinase activation, and whole cell patch clamp of cultured neurons and in slices) to assess the biochemical signature of CB1 tolerance and its modification in the S426A/S430A mouse. 3. What is the mechanism of delayed tolerance? In our preliminary studies we found that while tolerance was slowed in the S426A/S430A knockin mice, it still developed. This delayed tolerance is likely to be important in the adaptive responses to chronic CB1 receptor stimulation. In this aim we will take a discovery approach to identify potential mechanisms underlying delayed tolerance. We will use microarrays to determine the transcriptional changes that take place as tolerance to THC develops in wildtype and S426A/S430A knockin mice. We will also use mass spectrometry to test the hypothesis that delayed tolerance is due to additional CB1 receptor phosphorylation. Tolerance in the clinical setting is significant and often difficult to manage problem. The completion of these studies will be helpful both for managing tolerance to CB1 agonists as it occurs in the therapeutic setting as well as for understanding the consequences of sustained and high intensity recreational cannabis use.

Public health relevance
PUBLIC HEALTH RELEVANCE: Repeated use of cannabis, socially or therapeutically, leads to chronic adaptations in neurons where more drug is required to produce the same effect. This proposal tests the hypothesis that phosphorylation of two serines of the CB1 cannabinoid receptor is responsible for both tolerance and dependence that develop during chronic cannabis use. If these phosphorylation events underlie the adaptive changes that occur in neurons during cannabis use this will help us to better understand the implications of heavy cannabis use as well as sustained use of medical marijuana. Repeated use of cannabis, socially or therapeutically, leads to chronic adaptations in neurons where more drug is required to produce the same effect. This proposal tests the hypothesis that phosphorylation of two serines of the CB1 cannabinoid receptor is responsible for both tolerance and dependence that develop during chronic cannabis use. If these phosphorylation events underlie the adaptive changes that occur in neurons during cannabis use this will help us to better understand the implications of heavy cannabis use as well as sustained use of medical marijuana. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS CB1 cannabinoid receptors mediate the psychoactivity of cannabis, the most commonly abused illicit drug in the US, and are also attractive therapeutic targets. Sustained CB1 receptor activation, as happens with heavy and regular cannabis use, or with the therapeutic use of CB1 agonists, leads to the development of behavioral tolerance-a higher dose is required to produce the same effect. Alternatively, diminishing efficacy is seen with a constant dose. In the abuse setting, this may lead to escalating drug use, despite adverse consequences. In the therapeutic setting tolerance leads to diminishing efficacy and increased risk for side effects (as tolerance to side effects may develop at a slower rate than tolerance to the desired effect). Unraveling the response of CB1 receptors to sustained activation is important both for understanding the implications of chronic cannabis use as well as to rationally develop drugs that directly or indirectly target CB1 receptors. Earlier studies by us and others in simple preparations (e.g., cell culture models) indentified two serines in the C-terminus of the CB1 receptor whose phosphorylation desensitized CB1 signaling. To test the hypothesis that phosphorylation of these residues was necessary for the development of behavioral tolerance in an animal, we made a knockin mouse mutating these two residues to alanines (S426A/S430A). In preliminary experiments we have found that these mice, compared to wildtype mice are more sensitive to Δ9tetrahydrocannabinol (THC), develop tolerance to repeated administration of THC more slowly and also recover from tolerance more rapidly. Because of these very exciting preliminary findings we have proposed a series of experiments to fully understand the role of CB1 receptor phosphorylation in the development of behavioral tolerance to cannabinoids. We will do this by completing the following three specific aims: 1. What is the role of CB1 receptor serines 426 and 430 during the development of tolerance to cannabinoids? By using our S426A/S430A "knockin" mouse we will determine the role of phosphorylation of these two serines in the acute response to cannabinoids, in the development of cannabinoid tolerance and dependence, and in the severity of precipitated withdrawal. These experiments will particularly focus on the influences of dose and agonist efficacy. 2. How does preventing phosphorylation of serines 426 and 430 affect CB1 signaling during tolerance? In these experiments we will use biochemical and electrophysiological approaches (GTPγS autoradiography, MAP kinase activation, and whole cell patch clamp of cultured neurons and in slices) to assess the "biochemical" signature of CB1 tolerance and its modification in the S426A/S430A mouse. 3. What is the mechanism of "late" tolerance? In our preliminary studies we found that while tolerance was slowed in the S426A/S430A knockin mice, it still developed. This delayed tolerance is likely to be quite important in the adaptive responses to chronic CB1 receptor stimulation. In this aim we will take a "discovery" approach to evaluate potential mechanisms involved in delayed tolerance. We will use microarrays to determine the transcriptional changes that take place as tolerance to THC develops and how these changes are different in the S426A/S430A knockin. These studies will be accompanied by mass spectrometry investigations in wildtype and S426A/S430A mice as tolerance develops to determine the consequences of chronic THC treatment on CB1 phosphorylation and to test the hypothesis that delayed tolerance is due to additional CB1 receptor phosphorylation. Tolerance in the clinical setting is a significant and often difficult to manage problem. The completion of these studies will give us a comprehensive understanding of how tolerance develops to CB1 cannabinoid receptor agonists and the biochemical consequences of tolerance. This knowledge will be helpful both for managing tolerance as it might occur in the therapeutic setting as well as understanding the consequences of sustained social cannabis use.